Biomechanical factors for non-plantar ulcers in diabetic foot disease

ABSTRACT
Diabetic foot disease remains one of the most devastating consequences of diabetes, with the development of
a foot ulcer, its infection, amputation of the foot, and an increased overall risk of mortality an all-too-common
story for these patients. Veterans are more likely to be affected by diabetic foot disease, therefore it is essential
that we have a clear understanding of how these ulcers occur. Through wide-ranging in vivo and ex vivo
research, an extensive body of knowledge has been developed on the properties of the plantar tissues of the
foot and how these alter with diabetes, as well as how these changes increase the risk of ulceration. However,
a significant proportion of diabetic foot ulcers occur on other parts of the foot, such as the toes, heel, and dorsum,
and our understanding of how wounds at these locations develop and how to prevent and treat them is far less
established. The aim of this project is to begin to understand the biomechanical factors behind non-plantar ulcers
in diabetic foot disease and lay the groundwork for developing optimized strategies to prevent and treat them.
To achieve this, the proposed project will be based around two primary and one secondary aims. In Specific Aim
1, we will develop methods to determine the mechanical properties of foot tissue at common non-plantar
ulceration sites. A series of testing protocols will be established to allow the structural properties (including
compressive, shear, and frictional) of non-plantar cadaveric tissue to be characterized. Once these methods
have been established and validated, non-plantar sites on a pilot set of cadaveric feet (from donors with diabetes
and age/sex matched controls) will be tested to provide preliminary data that will help in the design of future
experiments. In Specific Aim 2, {eight} individuals with diabetic peripheral neuropathy and {eight} matched
controls will have their non-plantar pressures measured in a range of footwear conditions during a series of
standing and walking movements based around activities of daily living. This study will provide pilot data for
future work aimed at further characterizing these forces and developing interventions to reduce their incidence.
Finally, in the Secondary Aim we will review current technologies for shear force measurement regarding their
suitability to measure these types of forces, which may play a major role in non-plantar ulcer development, within
the shod environment. Overall, the impact of these novel techniques and data on the mechanisms behind non-
plantar ulcers could ultimately lead to a step change in our ability to screen for those at high risk of developing
an ulcer and could initiate new treatment strategies aimed at preventing or treating these injuries. Given the
increased risk the Veteran population is at for diabetic foot disease, reducing rates of ulceration in this group has
the potential to greatly lower the incidence of lower-limb amputations and improve the quality of life for our
Veterans. The results from this project will directly motivate and inform the submission of a Merit Review
application designed to achieve these longer-term goals.

Public health relevance
PROJECT NARRATIVE Veterans with diabetes are at high risk of developing wounds on their feet. These often become infected and can lead to the foot and leg being amputated. Most previous research in this area has focused on the best ways to prevent or heal wounds of this type that occur on the sole of the foot, often through specially designed insoles or footwear that can move pressure away from damaged or at-risk areas. However, a large proportion of these wounds occur on the other parts of the feet, for example the toes, heel, and top of the foot. Our understanding of how these wounds on the non-sole areas of the foot occur and how to treat and prevent them is far less advanced. This project aims to explore how this type of injury may develop by designing tests to study how the tissue in these areas change with diabetes and producing data on how loads are applied to these regions during daily activities. The information we gain will help us get to our goal of being able to design better interventions that can protect Veterans with diabetes from these wounds.